Analytical Services Core

Analytical Services Core: Project Summary/Abstract
The purpose of the Analytical Services Core (ASC) and two Subcores (Lipid and Oxidative Stress) is to provide
Vanderbilt Diabetes Research Center (VDRC) investigators with assays that measure plasma and tissue
hormones, cytokines, amino acids, lipids/lipoproteins, nucleotides, markers of oxidant stress, and GCMS
determination of isotopic enrichment and isotopomer distribution and mass used for metabolic flux analysis.
These services require unique instrumentation and involve rigorous standardization of procedures. It is neither
practical nor economically reasonable to establish these assays in individual laboratories. The consolidation of
services into one core laboratory provides investigators with efficient, high quality, low-cost analyses performed
by experts in the field. All services are tailored to meet the needs of the specific investigator in that the exact
protocol followed may differ depending on the analysis desired by the investigator and the sample volume to
be analyzed. Through training and education, investigators become more aware of the various services offered
and how these services might address specific areas of interest. Finally, an important function of the ASC is
method development, which not only enhances the spectrum of services offered but ultimately also increases
efficiency by providing researchers with the opportunity to expand their research programs. The core provides
space, equipment, and personnel for sample analysis. Investigators pay a fee-for-service that covers the cost
of reagents, supplies, pro-rated service contracts for equipment, and a percentage of personnel salary. The
core also serves as a valuable resource for investigators without ready access to wet-lab research space and
personnel. Core services utilize the latest instrumentation run by experienced research personnel in a
consistent, quality-controlled environment. The ASC works closely with other VDRC cores to develop standard
operating procedures to facilitate translation of this technology to VDRC investigators performing in vivo and in
vitro studies. Investigators rely on the Core and Subcore directors and their staff for advice on how to collect
and process samples collected during in vivo studies. Thus, the ASC provides essential services to VDRC
investigators that allow them to perform important and innovative diabetes research.